Apneic Oxygenation to Prevent Oxygen Desaturation During Intubation in the NICU

Tracheal Intubation (TI) is a common, life-saving, high-risk procedure for critically ill infants.
Adverse events occur in 18% of tracheal intubations performed in the NICU setting, and almost half
(48%) of NICU intubations are complicated by severe oxygen desaturation (≥20% decline in
pulse oximetry saturation [SpO2]). Severe desaturation is now recognized as an important
contributor to neonatal morbidity and impaired neurodevelopmental outcomes. While modifiable
factors have been identified that prevent adverse tracheal intubation associated events, there are
limited interventions that consistently prevent severe oxygen desaturation during intubation in
NICU patients.
Typical practice during intubation in the NICU setting is to remove respiratory support during
laryngoscopy and tracheal intubation attempts. Patients are often apneic during this period due
to pre-medication administration, a practice that is recommended by the American Academy of
Pediatrics. Apneic oxygenation is a strategy in which free flowing oxygen is provided via nasal
cannula during laryngoscopy and tracheal intubation. Apneic oxygenation has been demonstrated to
prevent or delay oxygen desaturation during intubation in adults and older children. To date, no
published studies have systematically assessed the impact of apneic oxygenation during intubation
for infants in the NICU setting. In this R21 application we propose a pilot randomized trial of
infants ≥28 weeks corrected gestational age who undergo tracheal intubation in the NICU
setting to determine if apneic oxygenation, compared with no respiratory support or oxygen during
laryngoscopy and tracheal intubation attempt, reduces the magnitude of decline in oxygen saturation
during tracheal intubation.

Public health relevance
PROJECT NARRATIVE Tracheal intubation in the neonatal intensive care unit (NICU) is frequently complicated by severe oxygen desaturation. Apneic oxygenation, a method of applying free flowing oxygen via nasal cannula to patients undergoing intubation, prevents or delays oxygen desaturation during intubation in adults and older children but has not been studied in NICU patients. We propose a randomized trial in infants undergoing intubation in the NICU to determine if apneic oxygenation, compared with no respiratory support or oxygen during laryngoscopy and intubation attempt (standard therapy), reduces the magnitude of oxygen desaturation during tracheal intubation.